Yale Training Program in Geriatric Clinical Epidemiology and Aging-Related Research

This is the fourth competing renewal of the Yale Training Program in Geriatric Clinical Epidemiology and
Aging-Related Research. The objective of the Yale Program is to develop a cadre of physician scientists and
PhD investigators (clinicians and nonclinicians) with expertise in geriatric clinical epidemiology and/or
translational aging research and equip them to address the myriad of unanswered questions concerning the
diagnosis, etiology, treatment, prevention, and prognosis of the health problems experienced by the ever-
increasing number of older persons. We will accomplish this objective by providing highly qualified physicians,
who are already well trained in geriatrics and/or subspecialties with age-related relevance, and outstanding
PhD investigators with 2 to 3 years of rigorous research training. Our trainees will develop skills in each of 11
essential areas: 1) formulation of significant and focused research questions and hypotheses; 2) design of
observational, mechanistic and/or experimental studies to address focused research questions; 3) techniques
to successfully execute specific study designs; 4) project and/or laboratory management; 5) critical analysis of
the scientific literature; 6) principles of data science; 7) interpretation of findings; 8) oral and written
communication of scientific methods and findings; 9) development and implementation of strategies for
research support; 10) research team approaches and leadership; and 11) budget management. These skills
will be developed through a training experience that includes both didactic and experiential components. The
didactic curriculum includes courses offered through the Clinician Scholars Program, Investigative Medicine
Program and School of Public Health, coupled with several high quality aging-specific training forums at Yale
and “off site”. The central component of the Yale Program is a mentored research experience, which includes
structured meetings with Program Faculty in geriatrics/gerontology and at least one supervised research
project tailored to the trainee’s experiences and interests, with the goal of producing one or more first-
authored, peer-reviewed publications and a grant application to support further research. The Yale Program
has successfully recruited and retained a full complement of outstanding trainees during each of the first 19
years, and has successfully placed many of its graduates in tenure-track, research-intensive positions at top-
tier academic institutions. For the next five years, we request continued funding for four postdoctoral positions.

Public health relevance
The objective of the Yale Training Program in Geriatric Clinical Epidemiology and Aging-Related Research is to develop a cadre of physician scientists and PhD investigators (clinicians and nonclinicians) with expertise in geriatric clinical epidemiology and/or translational aging research who will be equipped to address the myriad of unanswered questions concerning the diagnosis, etiology, treatment, prevention, and prognosis of the health problems experienced by the ever-increasing number of older persons.